Long-term impact of persistent parainfluenza virus infection

PROJECT SUMMARY
Seasonal respiratory RNA viruses, including human parainfluenza viruses (HPIVs) infect every child and
can reinfect individuals later in life. Globally, HPIVs are responsible for 725,000 hospitalizations and >34,000
deaths per year with HPIV1 being the major cause of croup. In addition to acute complications, severe disease
from HPIV infection early in life associates with the development of chronic lung pathologies, including asthma,
impacting a large fraction of the adult population. Based on observations in immunocompromised patients,
persistence of respiratory RNA viruses is suspected to drive the development and maintenance of these chronic
lung diseases. However, respiratory RNA virus persistence in immunocompetent hosts remains largely
understudied. Studies on the mechanisms and consequences of persistent RNA virus infections are critical to
expand our understanding of the biology, ecology, and evolution of common viruses of clinical importance and
may reveal solutions to debilitating chronic illnesses.
Infection of mice with the murine parainfluenza virus type 1 (best known as Sendai virus; SeV) results in
acute disease and virus clearance that is followed by the development of expanding pathology with
characteristics of type 2 inflammation, similar to what is observed during asthma in humans. Using
immunocompetent mice, we recently demonstrated the persistence of viral proteins and viral RNA in a subset of
hematopoietic cells infiltrating the lung. Persistently infected cells were found long after the acute infection was
cleared. We also showed that cells expressing persistent viral proteins had transcriptomic signatures consistent
with pathogenic chronic inflammation. Importantly, ablation of cells exposed to the virus significantly decreased
the severity of chronic lung inflammation, suggesting that viral persistence is a key factor in the establishment
and maintenance of chronic post-viral lower respiratory tract disease. Here, we will use this murine model to
determine where and how the virus persists in hematopoietic cells (Aim 1). We will also study the long-term
impact of SeV infection in the structural cells of the upper and lower respiratory tracts (Aim 2), and we will further
explore the long-term impact of parainfluenza virus infection on chronic post-viral disease and susceptibility to
future viral infections (Aim 3). Overall, our studies will advance our understanding of the mechanism mediating
the establishment and maintenance of persistent viral products, as well as the long-term impact of parainfluenza
virus infection on the host’s health. We expect that knowledge gained from these studies will be applicable to
other RNA respiratory viral infections that affect every child, including respiratory syncytial virus, human
metapneumovirus, and rhinoviruses.

Public health relevance
PROJECT NARRATIVE Persistence of respiratory RNA viruses is suspected to drive the development and maintenance of post- viral chronic lung diseases but RNA virus persistence remains largely understudied due to the difficulties accessing persistently infected cells in healthy humans. Our proposed studies using the murine parainfluenza virus SeV will advance our understanding of the mechanism mediating the establishment and maintenance of persistent parainfluenza virus, as well as the long-term impact of parainfluenza virus infection on the host’s health. Knowledge gained from these studies should be applicable to other RNA respiratory viral infections that affect every child, including respiratory syncytial virus, human metapneumovirus, and rhinoviruses.